A Microbial Model for the Formation of Calcium Oxalate and Calcium Phosphate Stones

Project Summary/Abstract
Urinary stones occur in 10% of people. The economic burden from urinary stones accounts for more than 2
billion dollars annually. Past studies have demonstrated that bacteria can be cultured from about one-third of
urinary stones and we have provided the initial demonstration that DNA sequencing coupled with enhanced
culture methods can be used to identify the urinary stone microbiota (the bacteria in urinary stones) in many
more stones than by standard culturing alone. Yet, critical knowledge gaps exist concerning the underlying
mechanisms of urinary stone pathophysiology. Alarmingly, prevalence of urinary stones is increasing,
and new treatments are not being developed. Although urine supersaturated with calcium oxalate has been
associated with stone formation, supersaturated urine is often present in non-stone formers. Accumulating
evidence supports a bacterial role in urinary stone pathophysiology. First, bacteria aggregate to calcium oxalate
(CaOx), the type of crystal responsible for most urinary stone disease. Second, initial in vitro studies indicate
that bacterial flagella are important components in bacterial promotion of crystal aggregation. Third, bacteria
increase the size of crystal clusters in an in vivo murine model. Our long-term research goal is to develop new
urinary stone treatment strategies that reduce urinary stone recurrence.
We hypothesize that flagella directly contribute to lithogenesis. To begin to determine the functional role of
flagella in stone formation, we will test bacterial mutants lacking key flagella components and/or function for their
ability to promote CaOx aggregation in vitro and in vivo. (Aim 1). Besides flagella, we also hypothesize that
other genetic factors may contribute to lithogenesis as well. We will perform a bacteria mutant screen to
identify non-flagellar genes involved in interactions with CaOx crystals. In addition, we will explore whether the
identified genes are enriched in bacterial isolates associated with stones relative to urinary isolates not
associated with stones (Aim 2).

Public health relevance
Narrative Urinary stones, a common and potentially serious medical problem, have long been associated with bacteria but the biological relevance of bacteria in stone formation has not yet been determined. Aim 1 will determine whether flagellar components and/or function affect calcium oxalate crystal aggregation in vitro and stone deposits in vivo; Aim 2 will identify non-flagellar genes involved in adherence of E. coli mutants l to CaOx crystals and explore whether the identified genes are conserved in Gram-negative urine and kidney stone isolates. Together, these Aims will discover direct bacterial contributions to calcium oxalate kidney stone disease.